Predicting trajectories of function, cognition, and quality of life among older adults with advanced lung cancer

PROJECT SUMMARY/ABSTRACT
Older adults with non-small cell lung cancer (NSCLC), the leading cause of cancer mortality, are at
increased risk for treatment toxicity, which can lead to impairments in physical function, cognition, and quality
of life (QOL). Maintaining function, cognition, and QOL is critically important to older adults with cancer,
especially as they are living longer with advanced cancer where toxicity is often cumulative. Older adults with
advanced NSCLC currently lack vital information about how systemic treatment will affect these patient-
centered survivorship outcomes that they need to make informed decisions about their cancer care.
The overarching goal of this proposal is to develop and validate prediction models for trajectories of
function (Aim 1), cognition (Aim 2), and QOL (Aim 3) among adults aged >65 with advanced NSCLC during up
to 6 months of chemotherapy and/or immunotherapy with non-curative intent. These outcomes were selected
by older cancer patient stakeholders based on which outcomes matter most to them. This proposal builds
directly upon our ongoing observational cohort study of older adults with advanced NSCLC starting a new
systemic therapy (130 patients received chemotherapy and/or immunotherapy). Our preliminary work
suggested distinct groups of trajectories for function (instrumental activities of daily livings, life-space mobility,
Short Physical Performance Battery), cognition (Montreal Cognitive Assessment, which is sensitive to change
in this population), and QOL (EORTC QLQ-C30). To further assess memory and executive function, we piloted
the addition of two tablet-based cognitive assessments, Favorites and Match.
We now propose to conduct the largest prospective comprehensive evaluation of older adults with
advanced NSCLC through a Cancer and Aging Research Group collaboration between Kaiser Permanente
Northern California, Ohio State University, and University of Rochester. Together, we will recruit an additional
714 older adults with advanced NSCLC for a total sample of 844 (estimated 700 evaluable patients; the first
400 for the development cohort, the last 300 for the validation cohort). Participants will complete serial geriatric
assessments prior to treatment initiation and at 1, 2, 4, and 6 months (or until treatment discontinuation,
whichever occurs earlier). Our uniquely qualified multidisciplinary team has significant expertise in geriatric
oncology, geriatrics, rehabilitation science, neuropsychology, epidemiology, palliative medicine, and
biostatistics and includes two patient and caregiver stakeholder boards.
This study will provide generalizable evidence to predict individualized trajectories for important patient-
centered outcomes that oncologists can use to a) describe how a recommended NSCLC treatment will likely
impact an older adult’s function, cognition, and/or QOL depending on which outcomes are most important to
the patient and b) compare outcomes for different options during shared decision making. With this
information, older adults with NSCLC and oncologists can optimize supportive care for those at highest risk.

Public health relevance
PROJECT NARRATIVE Over 71% of patients with newly diagnosed lung cancer are aged >65 and more than 50% are diagnosed with advanced disease, resulting in a large growing population of older adults with advanced non-small cell lung cancer (NSCLC). This project will provide oncologists with pragmatic clinical tools developed with generalizable data to predict individualized trajectories for function, cognition, and quality of life for older adults with advanced NSCLC during chemotherapy and/or immunotherapy treatment. This project supports the National Institute on Aging’s goal to promote the health and well-being of older adults and to mitigate the impact of aging-related conditions.